Defining a cross-primed anti-tumor T cell signature to guide immunotherapy development

PROJECT SUMMARY/ABSTRACT
Immunotherapies such as checkpoint blockade have revolutionized cancer therapy, but responses are seen only
in a subset of patients. Though tumor-intrinsic factors such as tumor mutational burden (TMB) or IFNγ “inflamed”
signature partially predict sensitivity to checkpoint blockade, these correlations are limited—most patients with
“inflamed” tumors or high TMB still fail to respond. A critical step for efficacy of T cell-mediated immunotherapies,
including checkpoint blockade, is dendritic cell cross-presentation of tumor antigen (Ag) to CD8+ T cells. Cross-
presentation in vivo requires Batf3-expressing type 1 dendritic cells (cDC1), though these DC have additional
functions, including secretion of T cell-recruiting chemokines, driving tumor-reactive T cell (TRT) responses.
Because patients with cDC1-enriched tumors have improved responses to anti-PD1, we developed an in situ
vaccination (ISV) combining FLT3L, radiotherapy (XRT), and TLR agonism to enhance cDC1 cross-priming of
TRT and observed that ISV potentiated anti-tumor effects of PD1 blockade and induced systemic tumor
regressions in treated patients. Additionally, we have shown that adoptive transfer of tumor-specific T cells into
syngeneic RAG-/- mice clears tumors, while transfer into allogeneic RAG-/- mice fails to control tumor growth,
highlighting that APC cross-priming of CD8+ T cells is required for efficacy of antitumor T cells. Despite the critical
role of cDC1 cross-priming of CD8+ T cells for effective therapy, there is no established method for measuring T
cell cross- or direct-priming in vivo. Consequently, there is a critical need for methods to directly measure CD8+
T cell cross-priming for identifying novel therapeutic targets to enhance cross-priming, and to understand
mechanisms of therapy resistance. We hypothesize that cross- and direct-primed T cells, and ISV-primed vs
untreated T cells, will harbor distinct signatures, mirroring their differential antitumor efficacy. In Aim 1, we will
develop mouse models of cross- and direct-priming using H2Kd knockout, H2Kb-transfected, GFP/OVA-
expressing lymphoma and breast cancers and transfer of Ag-specific T cells into syngeneic and allogeneic
RAG-/- mice. We will sort tumor-reactive T cells and perform bulk RNA-seq and spectral flow cytometry to identify
a cross-primed CD8+ T cell signature. In Aim 2, we will use bulk RNA-seq and spectral flow cytometry to
characterize the T cell response to ISV and checkpoint blockade across tumors (lymphoma, breast cancer),
model antigens (GFP, OVA, luciferase), and endogenous tumor antigens. The outcome of this study will be
elucidation of a cross-primed CD8+ T cell phenotype and a novel immune monitoring technique that allows
targeted design of novel immunotherapies by targeting novel checkpoints or costimulators to increase cross-
priming of tumor-reactive T cells.

Public health relevance
PROJECT NARRATIVE Cross-priming of CD8+ T cells by conventional Type 1 dendritic cells (cDC1) is necessary for effective antitumor therapy, yet there is no established method for measuring T cell cross- or direct-priming in vivo. This project seeks to define a signature of cross-primed T cells using RNA-seq of tumor-specific T cells isolated from H2Kd-/- tumor-bearing mice that can only cross-prime T cells, or allogeneic mice that can only directly prime T cells via direct tumoral antigen presentation. This will produce cross- and direct-primed T cell signatures that can be used to guide design of immunotherapies by targeting novel checkpoints or costimulatory receptors, to monitor responses to immunotherapy, and to predict responses to checkpoint blockade and similar therapies.